Elucidating the Role of Tryptophan Hydroxylase 1 in Neuroendocrine Prostate Cancer

Project Summary/Abstract:
Neuroendocrine prostate cancer (NEPC) is a fatal prostate cancer (PC) subtype with aggressive clinical
features and a poor prognosis. Although it rarely occurs de novo, treatment-induced NEPC shows a
significantly increasing incidence after widespread use of more potent antiandrogens for treatment of
castration-resistant prostate cancer (CRPC) in recent years, constituting up to 25% of advanced therapy-
resistant CRPC. Currently, NEPC remains incurable with a median overall patient survival of less than a year
from time of diagnosis. These dismal facts underscore a pressing clinical need to identify new molecular
determinants of NEPC pathogenesis and progression and develop an effective targeted therapy to prolong
survival. In preliminary studies, we found that tryptophan hydroxylase 1 (TPH1), the rate-limiting enzyme
responsible for biosynthesis of peripheral serotonin known as a neurotransmitter enriched in neuroendocrine
tumors and a classical neuroendocrine biomarker, is critically required for maintaining NEPC differentiation,
development and growth. Genetic or pharmacological inhibition of TPH1 in NEPC cells profoundly represses
neuroendocrine markers, cell proliferation and invasion, and xenograft tumor growth in mice. Importantly, our
data showed that TPH1 is upregulated in human NEPC and CRPC carrying neuroendocrine features relative to
prostatic adenocarcinoma in multiple independent patient cohorts. Mechanistically, our transcriptomic,
bioinformatic and biochemical analyses demonstrated that TPH1 activates mTOR signaling and subsequently
E2F1 and a NEPC-promoting oncogenic transcriptional program mediated synergistically by FOXM1 and TAZ.
These new findings support our hypothesis that TPH1 plays an active role driving NEPC and represents a
therapeutic target of NEPC. To test this hypothesis, Aim 1 will delineate the molecular mechanism of TPH1
signaling in NEPC, specifically dissecting how TPH1 activates the mTOR-FOXM1/TAZ/E2F1 signaling axis and
how this axis confers NEPC growth advantages and neuroendocrine traits in the context of TPH1. We will also
establish the clinical relevance of our mechanistic findings and assess their prognostic value in a large
collection of human advanced PC samples. Aim 2 will define the functional and biological impact of TPH1 on
NEPC differentiation, growth and progression using a series of in vitro and in vivo phenotypic and
pharmacological assays coupled with complementary human and mouse NEPC cells and organoids, cell line-
and patient-derived xenograft mouse models, and TRAMP transgenic mice. Successful completion of this
project will greatly deepen our mechanistic understanding of NEPC development and progression and provide
a compelling rationale for repurposing clinically available TPH1 inhibitors for NEPC therapy with quick
translational potential to benefit late-stage PC patients in the near future.

Public health relevance
Project Narrative Advanced prostate cancer has increasingly developed a lethal neuroendocrine phenotype as a consequence of widespread use of highly potent antiandrogens in castration-resistant prostate cancer. This is a significant clinical challenge raising an urgent need to develop new effective molecularly targeted therapies to improve patient survival. The proposed studies aim to define the mechanistic basis and functional role of tryptophan hydroxylase 1 and its downstream effectors in neuroendocrine prostate cancer. Our studies will provide new fundamental molecular insights into neuroendocrine prostate cancer pathogenesis and progression, laying the foundations for developing a repurposing targeted strategy capable of rapid clinical translation to treat neuroendocrine prostate cancer, which currently remains incurable.